TIMING OF ONSET OF CONTRACEPTIVE EFFECTIVENESS IN NORPLANT USERS

The objective of this study is to determine at what point after the insertion of the Norplant implant at which adequate contraceptive effectiveness is achieved.